Complete Mental Counts for Patients Recovering from Brain Injury

Abstract
Complete Mental Counts for Patients Recovering from Brain Injury
The ultimate vision is ubiquitous use of Complete Mental Counts (CMC)—akin to complete blood counts,
but based on behavioral measures of mental functioning versus biochemical measures of physiological health.
This project is focused on a particularly receptive market segment—“beachhead”—recovery monitoring for
patients with traumatic brain injury (TBI). Blast shockwaves and coup-contrecoup motion during TBI can cause
diffuse axonal injury throughout the brain, harming the networks that control mental functioning and resulting
in persistent symptoms. TBI symptoms tend to be heterogeneous and non-specific, undermining the discovery
and implementation of effective interventions while highlighting the need for objective measures of recovery.
Mental functioning is conceptualized along cross-diagnostic domains and dimensions that are grounded in
objective measures, from Movement Initiation, Dynamics, and Termination in the Reflexive domain to
Inhibition, Prediction, Attention, Memory, and Planning in the Cognitive Domain.
The goal of this project is to provide exceptionally sensitive and accessible measures of mental functioning
packaged as a software-as-a-service solution (SaaS) that is delivered to users via standard touchscreen devices.
This computerized assessment aid—MindCount, CMC precursor—can address unmet needs in clinical practice
and trials as well as support basic and translational research about the root causes of mental dysfunction, etc.
MindCount reports can have independent but synergistic uses: manage expectations based on prognosis,
motivate patients to engage in treatments that work, and inform clinicians if a change in treatment is warranted.
The key innovation is dynamic visuotactile measures to assess cross-dimensional mental functioning needed for
everyday life. A recent NSF SBIR Phase I project resulted in a tablet-based battery prototype and findings of
expected mappings between trial difficulty and performance (ex: faster-moving targets => larger tracking errors).
A subsequent pilot study found large case-control differences for cross-dimensional MindCount measures.
This project aims to expand, refine, productize, and validate the MindCount battery as a cross-dimensional
monitoring tool rather than a disease-specific diagnostic tool. This project aims to validate marketing claims that
MindCount can assess and track changes in mental dysfunction. Phase I will focus on inpatients and Phase II will
follow their recovery journey as they transition from inpatient to outpatient care. The primary success metric is
large effect sizes for MindCount measures. Secondary success metrics: high usability, good test-retest reliability,
significant correlations with symptoms and outcomes, smaller effect sizes for state-of-the-art behavioral tests.
Achieving the aims and publishing scientific papers will facilitate distributing MindCount to users and buyers.
Thought leaders—including target users and buyers—have expressed enthusiastic interest in MindCount.

Public health relevance
The proposed touchscreen measures of mental functioning would inform interventions for neurocognitive disorders after traumatic brain injury, akin to how blood work informs interventions for infection-triggered immune disorders. Innovations in human-computer interaction enable patient recovery monitoring with exceptional sensitivity and high accessibility through voluntary interactions with standard touchscreen devices. The ultimate benefits are novel assessment reports that support timely and personalized interventions, leading to better patient outcomes and lower societal costs.